Development of Novel Engineered Native Bacteria (ENB) for the Treatment of Familial Adenomatous Polyposis

PROJECT SUMMARY
Colorectal cancer (CRC) is the third most diagnosed cancer and the second leading cause of cancer death
globally. Most CRC develops from a histologically specific type of colon polyp i.e., adenoma. Around 1% of
these cases (i.e. approximately 20,000 per year) are attributed to a genetic condition called familial
adenomatous polyposis (FAP) and patients with FAP have a 100% chance of developing CRC, typically by
40 years of age. FAP is a hereditary cancer syndrome that is distinguished by the existence of numerous
synchronous polyps in the gastrointestinal tract, particularly in the large intestine and due to familial
involvement, the condition is often diagnosed early. Polyps typically start to form during childhood and grow
in size and quantity until adolescence. Removal of these polyps is a remedy, but not a permanent solution,
since they recur frequently. There are drugs for the suppression of these polyps, but they need to be
administered long-term and have substantial side effects. Moreover, prevention of FAP through colectomy is
costly, invasive, and life-altering. Thus, there is an urgent unmet need for a safe, efficient, cost-effective
and sustained therapy to suppress the further progression of colon adenomas, thereby reducing
incidence of CRC. Endure Biotherapeutics has developed an innovative technology, where native gut
bacteria expressing therapeutic gene products can be engineered to effectively colonize the gut and affect
host physiology through the expressed gene products. This platform technology can be used to express bile
salt hydrolase (BSH) gene in the gut and potentially suppress FAP. We have previously tested the
colonization hypothesis in mouse models by introducing a variety of genes, including those that affect host
metabolism and tumorigenesis, into the gut microbiome using a native E. coli strain. Recent, unpublished
studies in Dr. Amir Zarrinpar’s Lab with these BSH expressing bacteria have shown a strong suppression of
adenomas. Towards developing these engineered native bacteria (ENB) as a commercial therapy for colon
adenomas, this Phase I project, will focus on in vivo safety and efficacy studies of the ENBs in a mouse
model. We will also establish the safety, extent of colonization, and localization along the gastrointestinal
tract of the ENB in Yucatan mini-pigs, as a prelude to the Phase II, which will focus on IND enabling studies
like PK/PD, CMC and toxicology in this model. The Phase II project will culminate in the preparation of the
application for IND submission.

Public health relevance
PROJECT NARRATIVE Familial adenomatous polyposis (FAP) is a hereditary cancer syndrome that is distinguished by the existence of numerous synchronous polyps in the gastrointestinal tract, particularly in the large intestine. These polyps can turn into adenoma and lead to colorectal cancer (CRC). Thus, efficient removal of these polyps is a clinical priority. This SBIR Phase I project aims to establish engineered native bacteria as the ideal long-term one administration oral therapy for eliminating colon adenomas and reducing the incidence of CRC.